Mannose metabolism as a regulator of hepatic stellate cell activation and fibrosis

PROJECT SUMMARY
Mannose metabolism as a regulator of hepatic stellate cell activation and fibrosis
This proposal addresses the critical unmet need for effective anti-fibrotic therapies by elucidating an
unexplored pathway regulating activation of the hepatic stellate cell (HSC), a resident perisinusoidal cell type
that stores vitamin A in normal liver. However, among potential mechanisms driving HSC plasticity, sugar
metabolism pathways have been largely overlooked. The role of mannose metabolism in HSC biology has not
yet been examined, but recent high-impact studies, including ours (Shtraizent and DeRossi et al., eLife 2017),
implicate mannose as a mediator of obesity, diabetes, and cancer. Mannose phosphate isomerase (MPI) is the
key enzyme involved in catabolism of mannose; MPI mutation in humans leads to a congenital disorder of N-
glycosylation characterized by early and progressive liver fibrosis in children. Our data and these clinical
observations stimulated us to explore how the loss of MPI in this pediatric disorder leads to liver fibrosis. Our
exciting data find that: 1) MPI is decreased during HSC activation and fibrosis in rodents and zebrafish in vivo,
2) decreased MPI correlates with advanced stages of liver fibrosis in human HBV and NAFLD cohorts, and 3)
MPI depletion promotes HSC activation in human HSCs. Remarkably, mannose supplementation attenuates
HSC activation in a dose-dependent manner. Our objective is to understand the regulatory role of mannose
metabolism in HSCs and liver fibrosis. With the following aims, we will test our central hypotheses that
mannose metabolism is a critical metabolic pathway mediating HSC activation and attenuation.
Disruption of mannose metabolism, through loss of MPI, leads to HSC activation; conversely,
exogeneous mannose supplementation can attenuate HSC activation and liver fibrosis in vivo. Specific
Aims: Aim 1. Determine how MPI loss activates HSCs: By using primary rat HSCs and in vivo genetic
zebrafish models, we will investigate the role of O-GlcNAcylation in HSC activation, determine the cell-specific
effects of MPI-depletion, and test whether enhancing MPI activity can attenuate fibrogenesis following
exposure to well-established HSC activators. Aim 2. Determine the efficacy of mannose supplementation in
attenuating HSC activation in vitro and in vivo. This aim will use in vivo rodent models of fibrosis to investigate
how mannose supplementation modulates the plasticity of HSC phenotypes and test the extent of mannose to
attenuate liver fibrosis in vivo. Our long-term goal is to better understand the metabolic drivers of HSC
activation to manipulate these fuel-generating mechanisms and attenuate liver fibrosis. We will leverage our
expertise in the biology of a rare liver disease to advance our understanding of the metabolic regulation of HSC
activation, and to establish how this overlooked pathway of mannose metabolism can regulate HSC plasticity.
These studies are the first to investigate the antifibrotic roles of mannose supplementation and may reveal a
novel target and accessible therapeutic approach to suppress liver fibrosis.

Public health relevance
PROJECT NARRATIVE Mannosemetabolism as a regulator of hepatic stellate cell activation and fibrosis Chronic liver disease can lead to irreversible scarring of the liver, which can lead to liver failure, liver cancer, and necessitate liver transplantation. Currently, there are no approved medical treatments to effectively reverse scarring. This project proposes to investigate a new pathway involved in liver scar formation that can potentially lead to new drug targets.